Core A: Administrative

CORE A – ADMINISTRATIVE
ABSTRACT/PROJECT SUMMARY
There is no Abstract/Project Summary for the Administrative Core. See Specific Aims.

Public health relevance
CORE A – ADMINISTRATIVE NARRATIVE There is no Narrative for the Administrative Core.